Defining the role of tumoral MHC Class I Expression in Mediating Colorectal Cancer Racial Disparities

PROJECT SUMMARY
Compared to Whites, African American/Blacks (AA/B) have a substantially higher (40-50%) colorectal cancer
(CRC) mortality rate that is a function of both higher incidence and lower survival rates. Our long-term goal is
to understand the differences in immune response that influence this disparity in CRC mortality. Emerging
studies suggest alterations in T cell presence and function in AA/B contribute to CRC disparities, and AA/B CRC
patients with low immune infiltrate have particularly poor outcomes. We have found that AA/B CRC patients have
disproportionally reduced tumoral MHC class I expression compared with White patients. As MHC class I is
critical for presentation of tumor antigens to CD8+ T cells, these results suggest a critical immune mediated
mechanism that drives the differences in survival times between AA/B and White patients. The objectives of
this project are to understand the mechanisms relevant to T cell alterations within the tumors of AA/B versus
White patients and to develop improved biomarkers and therapies to reduce CRC racial disparities. Our central
hypothesis is that reduced tumoral MHC class I expression drives T cell alterations to enhance tumoral immune
escape in CRC from AA/B patients compared with White patients. To test this hypothesis, we have developed
robust multispectral imaging capability for studying the relationship between MHC class I expression and CD8+
T cell frequency, localization, phenotype, and function. In parallel, we have developed an autologous humanized
CRC TIL-PDX mouse model, created with matched patient-derived tumor and tumor infiltrating T cells (TILs) to
investigate CRC disparities. This completely unique approach will be undertaken by a multi-disciplinary team,
which includes a surgeon-scientist with expertise in CRC oncology, a cancer immunologist, and a cancer
disparities basic researcher. In Aim 1, we will define CD8+ T cell biology in the context of tumoral MHC class I
loss in AA/B versus White CRC patients. We will perform both multispectral imaging of archival tumor samples
and phenotypical/ functional studies of fresh samples to define essential differences between AA/B and White
tumors. In Aim 2, we will evaluate whether TIL-PDX mice generated from AA/B versus White CRC tumors exhibit
differential T cell biology and anti-tumor immunity in the context of tumoral MHC class I expression. We expect
that the use of the CRC TIL-PDX mouse model will recapitulates a patients’ tumor immunity in a manner not
previously possible to determine the differences in immune mediated processes. In Aim 3, we will assess the
ability of IL-15 as a therapy to overcome AA/B tumoral MHC class I loss using a syngeneic CRC tumor-bearing
mice. The positive impact of this work will be an improved understanding of the differences in immune-mediated
mechanisms to understand disparities associated with CRC patient outcomes and to develop a therapeutic
approach to help AA/B CRC patients.

Public health relevance
PROJECT NARRATIVE Previous research studies have shown that there are racial differences in immunotherapy outcomes for colorectal cancer. With the aid of a specially developed mouse model, tumor progression and immunity differences between patients with African American ancestry and Caucasian ancestry will be studied for this cancer. This project is relevant to public health and the research mission of the National Cancer Institute because we expect to lay a solid foundation for more effective immune-based therapies focused on African American patients with colorectal cancer.